Vet-LIRN Network Capacity Building Projects

Project Summary Breathitt Veterinary Center Vet-LIRN Network Capacity-Building Project Funding Opportunity Announcement Number PAR-18-604 As a part of the Breathitt Veterinary Center’s Vet-LIRN Network Capacity Building, it has been identified that new CO2 incubators are necessary. CO2 incubators are an important part of the microbiology section protocols. Microbiology and molecular diagnostics both depend heavily on the growth and reproduction of organisms recovered from a diseased animal. All of these organisms grow more efficiently under controlled environments where temperature, humidity and CO2 levels are at optimum levels. A CO2 incubator is used to keep these parameters at constant, optimal levels for specified times necessary to grow bacteria.

Public health relevance
Research Strategy Vet-LIRN Network Capacity-Building Projects PAR-18-604 The Breathitt Veterinary Center (BVC) is a part of the Vet-LIRN network and seeks to ensure that the laboratory is well equipped to meet the public health and safety goals of the network. In an effort to be better prepared to meet any potential needs, BVC seeks to purchase a CO2 incubator for use in microbiology. A CO2 incubator is recommended for growing bacterial cultures in several situations. CO2 incubators are typically heated to 37°C and maintain 95% relative humidity and a CO2 level of 5 percent. Microbiological incubators are essentially temperature-controlled ovens that work within the biological range of 5ºC to 70ºC and are mostly used for growing and storing bacterial cultures. Most incubator units are water-jacketed, air-jacketed or use direct heat to maintain the temperature around the culture chamber. When attempting to isolate bacteria that are suspected of contaminating animal food sources, the use of the CO2 incubator is recommended in several situations. Brucella species grow well under the effects of CO2. Brucellosis affects both man and animals and while not usually a feed contaminant, is a significant biological hazard. Salmonella, Shigella, Escherichia, Listeria and Klebsiella species, all of which are common food contaminants are facultative anaerobes, growing well under CO2 supplementation in the CO2 incubator. A CO2 incubator allows for a increase in the levels of CO2 in the incubation chamber compared to normal CO2 concentration in the atmosphere. This elevated level more naturally mimics the concentration of CO2 in the body. The increase in CO2 along with special media allows for an increase recovery of food pathogens such as Staph. Aureus, Brucella, E. coli, Salmonella, Shigella and Listeria.